Spatiotemporal Modulation of PIP[3]Signaling in Prostatic Tubulogenesis

DESCRIPTION (provided by applicant): This proposal describes the five-year career development plan of a physician-scientist with clinical expertise in urologic pathology who is committed to establishing an independent laboratory focusing on prostatic epithelial morphogenesis and migration. She will add to her scientific training with coursework in developmental biology, cellular migration, and cutting-edge live-cell imaging techniques. The research will take place in the Center for Cell Dynamics, a state-of-the-art multidisciplinary center at the Johns Hopkins School of Medicine that brings together experts studying spatially and temporally regulated molecular events in living cells. The proposed research project will focus on elucidating the signaling pathways that drive prostatic epithelial morphogenesis and are potentially re-activated in adult diseases of abnormal prostate growth. This project will bring together the strengths of her two scientific mentors, Dr. Denise Montell, an international expert in the basic science of epithelial cell migration, and Dr. David Berman, a urologic pathologist with a laboratory focused on prostate development and disease. Despite the highly conserved role of PIP3 (phosphatidylinositol [3,4,5]- trisphosphate) signaling in regulating cellular polarity, the role of PIP3 signaling in mammalian epithelial morphogenesis remains unknown. Based on preliminary data, we hypothesize that spatiotemporal modulation of PIP3 signaling is critical for two key processes driving prostatic tubulogenesis: prostatic ductal elongation and apicobasal polarity specification. Taking advantage of a 3D prostate epithelial culture system developed in our laboratory, as well as in vitro prostate organ culture and state-of-the-art time-lapse imaging techniques, we will examine the effects of PIP3 modulation on prostatic epithelial morphogenesis in three inter-related Aims: 1)We will establish the intracellular localization of and requirement for PIP3 signaling during prostatic ductal elongation using mice transgenic for a PIP3 biosensor and isoform-specific PI3K (phosphoinositide-3-kinase) inhibitors; 2)We will define the cellular mechanism by which PIP3 signaling regulates prostatic ductal elongation by examining the specific effects of PI3K inhibition on prostatic epithelial migration, proliferation and apoptosis; 3)We will examine the role of PIP3 in regulating apicobasal polarity by modulating the activity and levels of PI3K and PTEN (phosphatase and tensin homologue) in vitro during acinar morphogenesis and in vivo using a novel transgenic mouse line established in our laboratory. By elucidating the signaling networks that drive prostatic growth during development, we will better understand how dysregulation of these pathways may lead to prostatic disease in the adult.

Public health relevance
PUBLIC HEALTH RELEVANCE: There is increasing evidence that many of the signaling pathways that regulate prostatic growth during embryonic development are reactivated in adult diseases, such as benign prostatic hyperplasia and cancer. We have preliminary data that suggests the PIP3 signaling pathway is important during prostatic development, and we propose to study how its activation may enable the growth of prostatic epithelial tubules. This pathway is of particular interest because there are numerous drugs available for modulating its activity that may be useful for the treatment of human prostate diseases once we fully understand how the pathway works. 7. PROJECT NARRATIVE There is increasing evidence that many of the signaling pathways that regulate prostatic growth during embryonic development are reactivated in adult diseases, such as benign prostatic hyperplasia and cancer. We have preliminary data that suggests the PIP3 signaling pathway is important during prostatic development, and we propose to study how its activation may enable the growth of prostatic epithelial tubules. This pathway is of particular interest because there are numerous drugs available for modulating its activity that may be useful for the treatment of human prostate diseases once we fully understand how the pathway works. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS The developmental process of prostatic tubulogenesis, in which epithelial buds from the urogenital sinus invade into the surrounding mesenchyme and form a network of interconnected tubules, bears resemblance on both morphologic and gene expression levels to adult conditions of abnormal prostate growth. However, in part due to the paucity of 3D prostate culture systems, the signaling pathways that regulate prostatic epithelial morphogenesis remain largely unknown. To address this problem, we have developed a novel 3D embryonic prostate epithelial culture system that will allow us to use live-cell imaging techniques to probe the signaling pathways and cellular mechanisms driving prostate tubulogenesis. Epithelial tubulogenesis requires cells to regulate polarity, the asymmetric organization of the cell membrane and cytoplasmic structures, allowing them to accomplish two critical tasks: 1) epithelial migration with directed ductal elongation and 2) lumen formation with apicobasal polarity specification (Fig. 1). Significantly, the phosphatidylinositol (3,4,5)-trisphosphate (PIP3) signaling pathway, one of the most commonly dysregulated pathways in prostatic disease, plays a critical and highly conserved role in a number of polarity- driven processes. The specific hypothesis in this proposal is that spatiotemporal modulation of PIP3 signaling is critical for two dynamic processes underlying prostatic tubulogenesis: directed ductal elongation and apicobasal polarity specification. This hypothesis will be tested with three aims and is based on the following: 1) PIP3 signaling is active during murine prostatic epithelial budding; 2) inhibition of phosphoinositide-3-kinase (PI3K) attenuates prostatic ductal elongation in vitro; 3) PIP3 is confined to the basolateral plasma membrane during apicobasal polarization; and 4) loss of the apical PIP3 phosphatase, PTEN (phosphatase and tensin homologue) results in abnormal apicobasal polarization. AIM I. Establish the intracellular localization of and requirement for epithelial PIP3 signaling during prostatic ductal elongation. Hypothesis: Spatiotemporal regulation of isoform-specific PI3K activity is necessary for prostatic ductal elongation. Experiments will: A)Examine dynamic changes in PI3K activity in a 3D prostate tubulogenesis system via live-cell confocal microscopy using mice transgenic for a PIP3 biosensor; B)Delineate the spatiotemporal expression pattern of PI3K activity during prostatic development in vivo using real-time PCR, immunoblotting and indirect immunofluorescence for PI3K isoforms; and C)Determine the specific contribution of PI3K modules to prostatic ductal elongation using isoform-specific PI3K inhibitors. AIM II. Define the mechanism by which PIP3 signaling regulates prostatic ductal elongation. Hypothesis: PI3K activity regulates prostatic ductal elongation via modulation of epithelial cell migration, proliferation and/or apoptosis. Experiments will: A)Examine the modes/rates of epithelial cell migration following in vitro PI3K inhibition in a 3D prostate tubulogenesis system via live-cell confocal microscopy; B)Examine the relative rates of epithelial cell proliferation (BrdU) and apoptosis (TUNEL) following in vitro PI3K inhibition in prostate organ culture; and C)Determine whether effects of PI3K inhibition on ductal elongation are reversible in prostate organ culture by ectopic exogenous PIP3 addition or drug washout. AIM III. Demonstrate an essential requirement for spatial regulation of PIP3 signaling in the specification and/or maintenance of prostatic apicobasal polarity. Hypothesis: Modulation of basolateral PIP3 signaling during prostatic tubulogenesis will perturb prostatic apicobasal polarization. Experiments will assess the degree of apicobasal polarization by DIC and electron microscopy as well as immunofluorescence following: A)Pharmacologic inhibition and siRNA knockdown of PI3K and PTEN in a 3D prostate acinar culture system; B)Specific perturbation of basolateral PIP3 signaling via transfection with a constitutively membrane bound PTEN (PTENA4) or ectopic exogenous PIP2 addition to acinar cultures; and C)Inducible prostatic PTEN inactivation using a novel mouse model (ROSA(ER)-Cre PTENloxp/loxp mice) in prostate organ culture and in long-term renal grafting experiments. Unraveling the dynamic role of PIP3 signaling in prostatic tubulogenesis is essential for our understanding of prostatic growth and differentiation. Additionally, we will gain critical insight into how dysregulation of PIP3 signaling may contribute to abnormal prostate growth in the adult and how specific pharmacologic modulation of the pathway may be of therapeutic benefit in diseases such as benign prostatic hyperplasia. ductal lumen elongation formation Aims I,II: PIP3 modulation of ductal elongation Aim III: PIP3 modulation of apicobasal polarity Figure 1: A model of epithelial tubulogenesis.